Mechanisms of CD4 T cell help to myeloid cells in tuberculosis

ABSTRACT
CD4 T cells govern host control of M. tuberculosis (Mtb) infection. The diverse phagocytic myeloid cells
that harbor intracellular Mtb in the lungs require CD4 T cell help to activate antibacterial effector mechanisms.
Protection against tuberculosis (TB) depends on this cellular interaction, but it remains incompletely defined.
In our preliminary studies, we discovered that myeloid cells in the lungs of Mtb infected mice critically
depend on T cells to deploy a broad program of transcriptional activity that controls intracellular infection.
These pathways, constituting the spectrum of T cell help, included some pathways known to be due to
adaptive immune function, but also others that are canonically considered innate. Despite the heterogeneity of
myeloid cells in the lungs, most T cell dependent pathways were shared by MHCII+ antigen presenting cells
(APCs) and non-antigen presenting cells, like neutrophils. Using adoptive transfer, we found that CD4 T cells
were both necessary and sufficient for induction of the acute inflammatory response by MHCII+ APCs, as
marked by expression of SAA3. Concordantly, we found that expression of MHCII by monocyte derived APCs
was required for control of Mtb in the lungs. To advance understanding of how cell-cell contact mediated by
immune synapse formation between CD4 T cells and Mtb-infected APCs contributes to protection, we
developed a technique to identify and isolate physically interacting CD4+, MHCII+ multiplets from the lungs.
With these preliminary data and tools, we now aim to define mechanisms of CD4 T cell help in TB,
characterized as either direct (local, requiring cell-cell contact with APCs) or indirect (global, impacting both
APCs and non-APCs). Using adoptive transfer of CD4 T cells from wild type or knockout mice into T cell
deficient recipients, we will define how distinct CD4 T cell-derived effector functions drive myeloid cell
activation and control of intracellular Mtb among APCs and non-APCs. By advancing our studies of mice that
lack MHCII among monocyte derived APCs in the lungs, we will newly define how of antigen presentation in
the lungs drives different CD4 T cell functions and determine whether this differs depending on the antigen
recognized. We will test the hypothesis that antigen presentation by monocyte derived APCs governs
mechanisms of both direct and indirect help. With our innovative approach to isolating physically interacting
multiplets composed of CD4 effector T cells and Mtb-infected MHCII+ cells, we will discover bidirectional gene
expression programs that are highly associated with immune synapse formation in the lungs. We will use
ChipCytometry on sorted multiplets to spatially characterize the protein expression characteristics of each cell
contributing to the synapse. Using bone marrow chimeric mice, combined with bulk and multiplet-RNA-Seq, we
will determine the role and requirement of essential CD4 T cell effector functions in direct CD4 T cell help
delivered at the immune synapse. By providing new information about the ways that CD4 T cells protect the
host against TB, the studies will inform and accelerate the development of more effective TB vaccines.

Public health relevance
PROJECT NARRATIVE Tuberculosis remains a leading infectious cause of death worldwide, partly due to the lack of an effective vaccine. We seek to improve understanding of how CD4 T cells contribute to host protection, via their interactions with the myeloid cells that harbor Mycobacterium tuberculosis in the lungs. Using new approaches to clearly link CD4 effector T cell functions to diverse myeloid cell activation pathways in vivo, to define the role of MHCII antigen presentation in the lungs in CD4 T cell help, and to characterize the physical interaction of these cells, these studies will provide new information to guide and accelerate TB vaccine development.